Shape Distortions seen by Amblyopic Children: Pereceptograms and Neural Models

PROJECT SUMMARY
Children need to learn many shapes, especially letters and numbers for reading. Amblyopic children read 25%
slower than normal controls even when using both eyes. Although problems with fixation and saccadic control
have been identified, shape misperceptions have not been examined. Striking perceptual distortions have been
reported when amblyopic adults are asked to describe or draw oriented sinusoidal gratings or letters at sizes
well above their visual acuity threshold. Shapes are processed through orientation selective neurons in primary
visual cortex (V1), and a person would be severely handicapped in using vision if orientations were encoded or
decoded erroneously. The distortions reported by roughly two-thirds of adult amblyopes are important because
they are not explainable by existing theories of neural scrambling or shifts in the neural map but are compatible
with aliasing by reduced neural sampling of orientation in V1. We have built a theory about how early
differences between eyes in visual resolution or alignment impair development of cortical orientation selectivity.
We discovered that amblyopes have a greater loss of acuity and salience for luminance increments (ON
system) than decrements (OFF system). We also showed that a mosaic of cell properties, including spatial
resolution and orientation selectivity, develops in V1 depending on the spatial gradient of ON and OFF balance
in inputs to cortex. Together these two studies imply that the ON/OFF imbalance created by amblyopia will
reduce spatial resolution and orientation selectivity in populations of V1 neurons. We are currently testing
aspects and implications of this model for adult amblyopes. However, a critical missing piece for understanding
the development of shape perception is knowing whether amblyopic children see distortions, what form these
distortions take, when and how they develop, and whether they respond to treatment. If we could picture what
amblyopic children perceive, we could answer these and many other questions. The drawings that 4–7-year-
old children with amblyopia make of their percepts are unlikely to be accurate renderings, so we propose to
adapt Generative Adversarial Networks to generate perceptograms that match in the good eye what the
children perceive when they are shown gratings to the amblyopic eye. The image generating architecture will
be trained on 30,000 sums of sines, and the adversarial discriminator driven by repeated choices of the closest
match among multiple alternatives. A normal V1 model using marginal and correlational statistics of oriented
cells will be used to compare responses of the perceptograms and their evoking stimuli, then reduced in
coverage and selectivity to generate perceptogram responses from stimulus gratings. The model will be used
to predict amblyopic children’s perceptograms of printed and handwritten letters and numbers from the
EMNIST database, and the critical ones will be measured to understand if perceived shape distortions hamper
reading and learning. This project will thus introduce powerful new tools to amblyopia research that are also
likely to be used for many other childhood visual disorders.

Public health relevance
PROJECT NARRATIVE Amblyopia is the second biggest cause of vision problems in children, and negatively impacts their life including reading performance. Adult amblyopes draw distorted percepts of gratings and letters that indicate abnormal development pf orientation processing in cortex, and such distortions would hamper children’s reading and learning, but it is not known when these distortions first occur, how they develop, and if they respond to treatment. Children’s drawings are unlikely to be accurate representations of percepts, so to answer these questions, we will use Generative Adversarial Networks to make perceptograms of the distortions amblyopic children perceive in gratings, letters, and numbers. In parallel we will build neural models of orientation encoding and decoding that provide insights into the development of perceived shape distortions. These tools will transform studies of childhood amblyopia and possibly other childhood visual disorders.